Lab Research Training in Pediatric Oncology-Hematology

Project Summary
To continue to make progress for pediatric oncology patients, we need to perpetuate the pool of talented and
trained pediatric oncology-hematology physician-scientists who will make relevant discoveries and provide
investigative leadership. This has become ever more challenging in the field of pediatric oncology, as there
continues to be a shortage of young investigators with extensive laboratory research expertise. Fortunately, we
are able to attract candidates willing to spend the time in the laboratory under the tutelage of outstanding
investigators who are able to inculcate them with the culture of research that predominates at Johns Hopkins
Medical (JHM) and the National Cancer Institute (NCI), despite the current challenging funding climate. This
grant, institutional funds, and additional funding obtained by many trainees after two years in the laboratory
allows the large majority of trainees to continue for at least three years, with many staying on at the Instructor
level for additional time until they are fully ready to establish their own laboratory. In the current funding period
(07/2018 – 09/2022), this grant has supported superb laboratory research training for an outstanding group of
17 physician-scientists (12 MD and 5 MD/PhD) who have demonstrated a high degree of productivity and
commitment to careers in cancer research. Three of the MDs enrolled in a PhD graduate program while also
receiving T32 training, and we anticipate more will do so in the future. This application seeks continued support
for 8 interdisciplinary postdoctoral research positions per year. On average, we anticipate that 3 new trainees
will be appointed to this T32 Program each year. These highly selected physician-scientists will have completed
the clinical year of their fellowship. These strongly qualified trainees will be provided intensive three-year
research experiences that will prepare them for careers in cancer research. Trainees work on projects relevant
to the full range of childhood cancers, in the laboratories of leading scientists. Areas of faculty research expertise
include pediatric leukemias, lymphomas, sarcomas, brain tumors, neuroblastoma, cancer genetics and
epigenetics, cancer immunotherapy, stem cell transplantation, and small molecule drug development. The T32
trainees will receive extensive mentorship, not only from their primary laboratory mentor but also from the T32
Executive Committee and members of their Scholarship Oversight Committee, will participate in grant-writing
workshops and have their grants reviewed by a T32 faculty committee, and will receive instruction in biostatistics,
the responsible conduct of research, and additional topics in courses selected by the trainees. They will be
provided career guidance via presentations from former T32 trainees now pursuing pediatric oncology research
careers in academia, industry, and government, will be given the opportunity to present their research in multiple
forums to develop their oral and critical thinking skills, and will participate in a pediatric oncology laboratory
research-specific Journal Club. The trainees and their mentors participate in an interactive, dynamic research
environment bridging the JHM and the NIH, with an emphasis on translational approaches in pediatric oncology.

Public health relevance
Project Narrative This program provides postdoctoral education, training, and experience in field-leading laboratory research on childhood cancers for pediatric oncology-hematology physician-scientists. It ensures that a pipeline of well- trained physician-scientists can continue the progress that has been made in the treatment of these life- threatening diseases affecting children.